Cannabis Legalization: Assessing its Impact on Treatment for Substance Use Disorders

Abstract
Understanding the impact of recreational cannabis legalization on treatment of substance use disorders (SUD)
is the goal of this research. Drawing upon treatment centers recruited in our prior studies, we propose to collect
two waves of organization-level data from 350 SUD treatment organizations comprising 3 mutually exclusive
groups: (1) centers located in states where recreational cannabis is legal (“legalization states”); (2) centers in
states that prohibit recreational cannabis but allow medical cannabis (“medical cannabis states”); and (3)
centers in states that prohibit medical and recreational cannabis (“prohibition states”). These three groups are
foundational to achieving the project’s Specific Aims, which are (1) to compare cannabis treatment admissions
in treatment centers located in legalization states, medical cannabis states, and prohibition states as well as to
examine changes in treatment admissions over time; and (2) to examine whether treatment delivery for
cannabis use disorder (CUD) is altered in response to legal recreational cannabis availability. Controlling for the
organizational, legal, and socioeconomic environment, we will examine admissions for cannabis for adults 21
and older and for individuals under age 21. We will examine heterogeneity in state cannabis laws, including
important nuances in policies toward dispensaries, home cultivation, and total production, to assess treatment
system impacts of each policy provision as well as to compare impacts of centers in early legalization states
(CO and WA) relative to centers in later legalization states. Based on substitution and complementary
hypotheses, we will also examine patterns of change in admissions for other SUD diagnoses, such as
nonmedical prescription opioids, and in sources of referrals, differentiating between clients with CUD from
those presenting due to a court mandate or in lieu of incarceration. Measures will examine changes in inter-
organizational relationships between centers and community institutions, such as educational institutions,
primary care, and the criminal justice system. Because treatment admissions may be affected by how states
are implementing health reform, we will control for state-level approaches to health reform as well as other
state-level characteristics. This study will also examine if and how screening tools and treatment practices are
adapted or reinvented to fit the needs of patients with cannabis-related problems. Using resource dependence
theory, absorptive capacity, and diffusion of innovation theory, we will compare the effects of organizational
and external socioeconomic and legal factors on the adoption of treatment practices for CUD, including off-
label use of medications. In addition, we will focus on management’s proactive strategizing (or absence
thereof) in response to legalization, such as adaptations in marketing campaigns. These innovative findings will
assist the SUD treatment field to build a body of evidence-based management strategies related to CUD
treatment, and will set the stage for understanding how these strategies are linked to organizational outcomes.
Addressing such questions is critical as other states consider cannabis legislation initiatives.

Public health relevance
Project Narrative Legal access to recreational cannabis may lead to increased substance use disorders associated with cannabis use. The proposed study will explore the consequences of recreational cannabis legalization for organizations specialized in the treatment of substance use disorders, and, in so doing, will address an emerging phenomenon for which there are essentially no other examples. The research will yield pragmatic data for treatment programs regarding effective responses to this policy change, as well as providing empirically-based policy implications for other locales as they consider legalizing recreational use of cannabis.